Multi-Scale Investigations of Respiratory Mucus/Mucin Structure and Function in Health and Disease

OVERALL ABSTRACT
The mucus clearance system constitutes the primary airway host defense system against inhaled infectious
agents and toxins. However, despite more than two centuries of research into the nature of the mucus clearance
system, surprising gaps in our knowledge of fundamental aspects of this system persist. Filling in these gaps is
important for improving public health strategies to combat respiratory infectious diseases. Filling in these gaps
is also important for elucidating the pathogenesis of and developing therapies for chronic pulmonary diseases,
including COPD, asthma, NCFB, and rare genetic diseases (CF, PCD), which are by definition characterized by
mucus accumulation in the lung. This PPG proposes to investigate fundamental, but poorly understood, aspects
of the mucus clearance system that must be quantitated to understand mucus function in health and dysfunction
in disease. Each PPG project has two specific aims focused on basic mucin function and one focused on
translational aspects of mucin pathobiology. Project 1 (“Mucin Structure and Associations in Respiratory Mucus”,
Michael Rubinstein, PhD, PI) will investigate fundamental aspects of the organization of mucins in solution and
within the mucus layer. These studies will be complemented by studies of the addition of “abnormal polymers”,
e.g., DNA, to mucus solutions. Project 2 (“Why are mucins so gigantic and is it safe/effective to sever them
therapeutically?”, Richard C. Boucher, MD, PI) will focus on the fundamental question as to why human airway
mucin polymers are of such enormous size (300 MDa, Rg 250 nm) and characterize the ratio of efficacy (chain
length reduction) vs risk (off-target chain unwinding) required for the development of mucolytics for lung disease.
Project 3 (“Membrane-bound mucins on the airway surface ensure efficient mucus clearance and lung health”,
Brian Button, PhD, PI) will study the relationships between cilia, PCL, and the mucus layer required for transport,
focusing on a novel hydraulic “pushing” vs classic “clawing” mechanisms. In addition, barrier functions of PCL
and regulation thereof will be studied. Project 4 (“Biophysical and structural characterization of airway
submucosal gland mucus in health and cystic fibrosis”, Ronit Freeman, PhD, PI) will focus on a novel attribute
of submucosal gland (SMG) mucus, a strand/bundle insoluble component, and how strands/bundles contribute
to SMG mucus function in health and disease. Three cores support the PPG: 1) Core A, the
Administrative/Biostatistical Core, Multi-PIs Richard C. Boucher, MD, and Michael Rubinstein, PhD, supplies
project management and statistical support for the PPG; 2) Core B, the Mucus/Mucin Analytics Core, PI Mehmet
Kesimer, PhD, provides quality control of all mucin reagents for the PPG and novel biochemical/biophysical
measurements; and 3) Core C, the Imaging Core, PI Camille Ehre, PhD, provides electron microscopic,
molecular, and morphologic analyses to the projects. The overall goals of the PPG are to elucidate the structure
and function of mucus in health, how these characteristics are degraded in disease, and identify strategies for
development of novel therapeutic agents to treat muco-obstructive diseases.

Public health relevance
PUBLIC HEALTH STATEMENT – OVERALL Failures of the mucus clearance system can produce consequences for the US population in the context of susceptibilities to inhaled infectious agents and environmental toxins. In addition, failure of the mucus clearance system produces a spectrum of muco-obstructive lung diseases, including COPD, asthma, non-CF bronchiectasis, and the rare genetic diseases cystic fibrosis and pulmonary ciliary dyskinesia. There is a great need to elucidate the normal structure and function of mucins to understand their roles in lung health and to develop strategies for the treatment of chronic failures of mucus clearance, i.e., patients with muco-obstructive diseases.